COBRE: UND: ADMINISTRATIVE CORE

This subproject is one of many research subprojects utilizing the resources provided by a Center grant funded by NIH/NCRR. Primary support for the subproject and the subproject's principal investigator may have been provided by other sources, including other NIH sources. The Total Cost listed for the subproject likely represents the estimated amount of Center infrastructure utilized by the subproject, not direct funding provided by the NCRR grant to the subproject or subproject staff. The Administrative Core will oversee all of the operations of the UND COBRE grant. Dr. Jonathan D. Geiger, who was recruited here to be Principal Investigator on this COBRE grant, will oversee and coordinate the research activities of the junior faculty members and he will be assisted in this by members of the Internal Research Directorate and the External Advisory Board. Dr. Geiger will Chair meetings of the junior investigators. This core will coordinate the meetings of the External Advisory Board, a seminar series, and an annual symposium. COBRE administrative funds will also be used for maintaining a vigorous Pilot grant program, enhancement of the Library of the Health Sciences, and creation/maintenance of our website.